Optimizing the Delivery of Diabetes Management During Breast Cancer Care

PROJECT SUMMARY
Twenty percent of US women with breast cancer also have diabetes mellitus (DM) and face a 50% higher risk
of death up to 10 years after cancer diagnosis compared to non-diabetic women with breast cancer. A possible
explanation is that DM receives less attention during cancer treatments because patients, oncologists, and
primary care providers (PCPs) prioritize cancer care over DM management. Oncologists may focus on cancer
care (rather than DM management), patients may not see their PCPs in the period after cancer diagnosis, and
PCPs may not feel comfortable managing DM in the context of chemotherapy regimens that frequently affect
glucose control. Given these concerns, identifying a provider who could effectively manage DM may be an
attractive solution. Nurse practitioners (NPs) have been successfully integrated into many oncology care teams
to support general cancer care. Separately, NPs have been shown to successfully manage DM in various non-
cancer settings. However, no study has determined whether a NP on the oncology care team can effectively
manage DM during chemotherapy for breast cancer. I hypothesize that a NP trained in DM care and
embedded in the oncology team can effectively manage DM during this acute phase of breast cancer care.
The objective of this study is to engage stakeholders to develop and implement a NP-led intervention to
manage DM for women receiving chemotherapy for incident non-metastatic breast cancer. To accomplish this,
I propose the following research aims: 1) elicit the perspectives of patients, NPs, oncologists, and PCPs about
barriers to and facilitators for a NP managing DM during chemotherapy, 2) develop a NP-led intervention to
manage DM during chemotherapy, and 3) conduct a pilot study to implement the intervention and assess
implementation outcomes (reach, acceptability, appropriateness, feasibility, fidelity). Findings from this pilot
study will lay the groundwork for a multi-site, randomized trial testing the effectiveness of this NP-led model.
As a PhD-trained health services researcher focused on cancer outcomes and health disparities, I have gained
quantitative research expertise. I now seek to expand my research skills to include implementation trials. To
accomplish this goal, I will pursue mentorship and training in qualitative research methods, healthcare delivery,
and in stakeholder-engaged intervention design, implementation, and evaluation in real-world settings. I will be
mentored by two nationally-recognized clinician scientists, Dr. Monika Safford and Dr. Lisa Kern. Together, we
designed a career development plan for me to gain skills through coursework and reading that is then solidified
through experiential learning by carrying out my research aims. This Award will enable me to advance toward
my long-term goal of becoming an independent health services researcher working at the intersection of
cancer care, primary care, and health equity to improve patient outcomes and reduce health disparities.

Public health relevance
PROJECT NARRATIVE Women with diabetes and breast cancer have a 50% higher risk of death up to 10 years after cancer diagnosis compared to non-diabetic women with breast cancer, which may be partially due to suboptimal diabetes management during active cancer treatment. The goal of this study is to develop and pilot test a stakeholder- engaged intervention to manage diabetes for women receiving chemotherapy for incident, non-metastatic breast cancer. Findings from this innovative pilot study will lay the groundwork for a future, multi-site, randomized trial testing the intervention developed here.